Research Education Component

Project Summary: Research Education Component (REC)
The overall goal of the Research Education Component (REC) is to identify, support, and nurture talented
junior investigators who will become national leaders in aging research, especially within our theme of late-life
disability in vulnerable populations. This renewal application builds on the success of the UCSF REC over the
past 4 years in identifying and fostering the development of an incredible talent pool of junior investigators
across multiple specialties (e.g., Dermatology, Geriatrics, Hospital Medicine, Hepatology, General Internal
Medicine, Neurology, Nursing, Oncology, Palliative Medicine, Social Science, Urology) towards independence
in aging research. Our primary mechanisms for continuing our track record of success are through the REC
Scholars and Advanced Scholars Programs. These programs target candidates of exceptional promise at
crucial points in their career. The REC Scholars Program targets early career faculty and seeks to accelerate
their path towards NIA K awards. They are provided generous levels of support designed to protect their time
as they develop a portfolio of manuscripts and research that will make them competitive for K-awards. The
REC Advanced Scholars Program targets current K award recipients and seeks to accelerate the path towards
their first R01. They are provided support that funds additional work that will be essential to a successful R01
application, but cannot be done with the limited project resources of their K-award. All REC Scholars and
Advanced Scholars also receive extensive mentoring support and participate in innovative educational
activities designed to develop skills essential to success in aging research. REC curricular efforts develop core
knowledge in aging topics, enhance manuscript and grant writing skills, leadership skills, facilitate
interdisciplinary communication, and support a Translational Science Fulcrum Program that accelerates
translation between basic and clinical aging research. REC leadership will also actively work with leaders of
the Resource Cores to provide each scholar access to additional support and services, which have been
central to the success of our scholars during our first cycle. The REC also sponsors a Diversity Supplement
Program to increase the number of faculty from underrepresented and diverse backgrounds conducting aging
research at UCSF and has a close partnership with the UCSF Resource Center for Minority Aging Research.
We are proud of the paradigm-changing work of our scholars who have published in the highest impact
journals, received prestigious grants, and become valued collaborators and partners in our mission to improve
the health and well-being of vulnerable elders.

Public health relevance
PROJECT NARRATIVE – Research Education Component (REC) Not applicable